DVLP &INCORPORATE ION PROBE SOFTWARE IN NEW PCLAMP FOR WINDOWS

WINDOWS OPERATED SOFTWARE IS THE PRODUCT BEING DEVELOPED IN COLLABORATION WITH AXON INSTRUMENTS (SEE LETTER BELOW). BY WORKING WITH THIS RESPECTED BIOELECTRONICS COMPANY WE HOPE TO SEE OUR POWERFUL NEW TECHNIQUES MADE WIDELY AVAILABLE TO THE SCIENTIFIC COMMUNITY. WE WILL WORK WITH THE COMPANY IN THE DEVELOPMENT OF THE SOFTWARE, MAKING IT AVAILABLE TO OUR VISITORS PRIOR TO ITS COMMERCIAL AVAILABILITY. THIS WILL ALLOW SIGNIFICANT INPUT FROM THE FACILITY IN ITS DESIGN. WE ALSO EXPECT TO GAIN IN EQUIPMENT CONTRIBUTED BY AXON INSTRUMENTS, AND AN EFFECTIVE OUTREACH.